Medication risks and challenges among people with dementia who live alone

PROJECT SUMMARY/ABSTRACT
One-third of older adults with dementia live alone. A crucial challenge facing this vulnerable, growing, and
understudied population is the safe and effective use of medications. Due to cognitive impairment, people with
dementia (PWD) are more likely to misuse medications and face a threefold increased risk of medication-
related hospital admissions compared to those without dementia. For older adults with dementia who live
alone, the situation is even more dire. PWD living alone are more likely to lack support with medication
management than those living with others. They are therefore potentially at higher risk of adverse drug events,
particularly when exposed to certain high-risk medications. Despite recognition of the vulnerability of PWD who
live alone, we lack reliable national data regarding medication use in this population. The objective of this study
is to characterize high-risk medication use (defined as medications with adverse cognitive effects and
medications with a low tolerance of misuse, including anticoagulants, hypoglycemics such as insulin, and
opioid medications) and medication management supports and challenges among PWD who live alone. Using
a nationally representative US cohort derived from merged National Health and Aging Trends Study (NHATS)
data and Medicare claims, we will investigate two specific aims: (1) To determine the prevalence of and risk
factors for high-risk medication use among PWD living alone and to compare this to PWD living with others
and (2) To characterize medication management supports and challenges among PWD who live alone
compared to those who live with others. We will determine medication use from Medicare Part D claims and
will elucidate medication management supports and challenges from NHATS self and proxy reports.
Significance & Innovation: Results from the proposed research project will directly inform clinical and policy
interventions to support community-dwelling PWD, including a sizeable fraction who are living alone. This
aligns with the National Institute on Aging's mission of promoting better quality of life for older Americans,
including those with Alzheimer's Disease and Related Dementias, and improving the safe use of medications
by older adults. This project is innovative because it will be the first to provide reliable national data regarding
what high-risk medications are prescribed in this vulnerable group and to identify health system,
patient/clinical, and social factors associated with these prescribing patterns. Describing medication
management supports and challenges will identify populations in greatest need of supportive interventions.
Future directions of this work include designing targeted interventions to improve the quality and safety of
medication prescribing and provision of supportive services for community-dwelling PWD who live alone.

Public health relevance
PROJECT NARRATIVE This research project utilizes nationally representative data from the National Health and Aging Trends Study linked with Medicare data to study high-risk medication use and challenges with medication management in community-dwelling people with dementia, with a focus on those living alone. The knowledge generated by this research will be relevant to public health by helping clinicians and health system leaders develop strategies to improve the quality and safety of medication prescribing and the provision of supportive services for this understudied and vulnerable group. Thus, the proposal is consistent with the National Institute on Aging's mission to advance knowledge to improve the treatment of common diseases and conditions of aging and specifically to promote knowledge about the safe use of medications by older adults.